TRAINING IN LOW FLOW CAPILLARY LC-ESI-MS/MS AND ETD

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Training for Wenzhu Zhang, Erica Jacobs, Sunnie Myung, Brian Reed, Zachary Quinkert, Kelly Molloy and Yinyin Lee in low flow capillary LC-ESI-MS/MS and electron transfer dissociation (ETD).